Modulation of Neuroinflammation in Glaucoma

PROJECT SUMMARY
Growing information from the studies of human glaucoma and experimental models supports that glia-driven
neuroinflammation creates an additional damaging force on retinal ganglion cell (RGC) somas, axons, and
synapses, and its therapeutic modulation can provide widespread neuroprotection. Our accumulated data from
recent studies of neuroinflammation in glaucoma led to our new hypotheses that we aim to test in this project.
Evidently, cFLIP functions as a molecular switch between caspase-8-mediated cell death/survival/inflammation
pathways through TNFRs, TLRs, and inflammasome, Our first Specific Aim will test whether conditional deletion
of astroglial cFLIP can inhibit the inflammatory outcomes caspase-8/cFLIP interaction and prevent/reverse the
inflammatory/neurotoxic astrocyte phenotype in experimental glaucoma. We expect that deletion of cFLIP in
astroglia will selectively target inflammatory/neurotoxic (A1) astrocytes (because these cells are primed for
inflammatory caspase-8 functions through TNF-α/TNFR, Fas/FasL, TLRs, and inflammasome) and will provide
immunomodulation (without risking the glial neurosupport functions). Besides cFLIP, we will selectively target
cFLIPL to also determine isoform-specific differences in inflammatory outcomes and cell fate decisions. We will
analyze spatial and temporal responses to astroglial cFLIP (or cFLIPL) deletion by morphological and molecular
analysis of retina and optic nerve astroglia, including inflammatory responses, A1/A2 astrocyte distribution, cell
death (apoptosis/necroptosis), and neurosupport functions. Elimination of astroglia-driven inflammation can
protect RGCs against inflammatory injury in experimental glaucoma. Our Specific Aim 2 will test this hypothesis
by analysis of neuron survival (by RGC axon/soma counting) and function (by PERG). Astroglia and microglia
closely interplay and regulate each other’s phenotype and immune functions. Our recent research findings also
supported that astroglial cytokine responses may shape microglia responses in experimental glaucoma. Our
Specific Aim 3 is therefore designed to test whether glial subtype-specific deletion of cFLIP (or cFLIPL) can impact
individual contributions and the cross-talk between astroglia and microglia during neuroinflammation. We will
analyze microglia responses (including M1/M2 conversion) to astroglial deletions, and and astroglia responses
(including A1/A2 distribution) to microglial deletions at different sites/time points. Longitudinal analysis will also
include oligodendrocyte and Müller glia responses. Through the analysis of cell type-specific responses (including
the molecular responses of isolated glial subtypes) to glial subtype-targeting mouse models, this project will value
glial cFLIP as an immunomodulatory treatment target to prevent/reverse neurodegenerative inflammation in
experimental glaucoma. Outcomes of this project are also expected to be widely useful in studies of other
ocular/neurodegenerative/neuroinflammatory diseases, aging, stem cell/axon regeneration, and cancer research.

Public health relevance
PROJECT NARRATIVE Glaucoma is a leading cause of blindness; however, current treatment strategies are not sufficient to prevent progressive injury to specific nerve cells (called optic nerve) and continuous loss of visual function. The proposed project aims to determine the disease-causing importance of a molecule (called cFLIP) by modeling glaucoma in specific mouse strains lacking this molecule in glia (that are adjacent to nerve cells) and testing the effects on inflammatory nerve injury (that can be induced by glia). We expect that the information collected through this project will eventually help develop new treatment possibilities for millions of Americans suffering from this blinding disease and will also be useful in various other fields of medical research.